T32 Cancer Prevention and Control Postdoctoral Training Program

PROJECT SUMMARY/ABSTRACT
The University of Arizona Cancer Center (UACC) T32 Cancer Prevention and Control Training Program
Addressing Health Disparities is designed to advance the independent careers of diverse scientists. The
program benefits from the success of training nine postdoctoral Fellows during the first T32 grant period, all of
whom are from underserved populations (including 5 Hispanic/Latino and 2 Native American scientists),
access to the diverse population in Arizona who suffer significant cancer disparities, and on the 23-year history
of UACC preparing outstanding cancer prevention and control (CPC) scientists. This T32 Program will support
the training of four postdoctoral positions annually with a maximum of 10 postdoctoral trainees supported over
five years. The program’s primary goal is to train a diverse workforce of independent CPC scientists
working to reduce cancer health disparities. Our aims include: 1) Recruit outstanding and diverse
applicants committed to careers in cancer prevention and control research with an emphasis on cancer health
disparities; 2) Engage Fellows in a high quality, comprehensive training program that establishes their
independence as cancer prevention and control scientists; and 3) Evaluate the program regularly and actively
respond to program enhancement opportunities. The Program includes a structured curriculum in CPC and
health disparities sciences while supporting individualized career development plans. The training program
design supports trainee outcomes including independence in research and high productivity in academically
relevant metrics of success (grants, manuscripts and scientific presentations). The Program is based on strong
mentorship from a faculty representing diverse disciplines and deep experience working in diverse populations.
Program evaluation is operationalized throughout the training to assure ongoing quality improvement. Specific
fellowship activities of the training plan include: 1) Completion of required elements of the core curriculum and
elective curriculum elements tailored to meet each postdoctoral Fellow’s training and professional goals; 2)
Participation in mentored research experiences; 3) Submission and publication of peer-reviewed journal
articles; 4) Presentation of work at scientific conferences; and 5) Preparation and submission of a research
proposal for funding. This proposed training program aligns with the University of Arizona’s strategic plan and
addresses the needs of our State’s unique population, including high numbers of Hispanic and American
Indian residents, rural and border communities, aging population, and areas of persisting poverty. This
distinctive geographic location along with our strong community ties, university partnerships, CPC postdoctoral
training history, and university infrastructure and resources uniquely position us to continue to expand the next
generation of diverse CPC researchers focused on reducing health disparities and working with underserved
communities.

Public health relevance
PROJECT NARRATIVE There continues to be a need to improve the quality and quantity of cancer prevention and control research focused on cancer health disparities, as well as to increase the number of scientists from these underrepresented groups. The overall goal of this T32 Cancer Prevention and Control Training Program Addressing Health Disparities is to facilitate the training of a diverse workforce of cancer prevention and control scientists working in underserved populations to reduce cancer health disparities. This multi-faceted, postdoctoral training experience includes the conduct of a specialized research project, didactic instruction, team science experiences, and individual multidisciplinary mentoring teams of highly experienced and peer reviewed research funded faculty investigators, all to assure the development of quality cancer health disparities researchers.